Therapeutic targeting of IRAK4 in MDS

PROJECT SUMMARY/ABSTRACT
Spliceosome mutations and alterations in RNA splicing are common in myelodysplastic syndrome
(MDS), yet the specific oncogenic changes due to these alterations have not been fully identified.
We demonstrated that overexpression of an active isoform of the serine/threonine kinase, IRAK4,
is seen in MDS. The active long IRAK4 isoform (IRAK4-L) consists of an N-terminal death domain
(DD) and C-terminal kinase domain (KD), which stochastically assembles with the Myddosome
complex and results in maximal activation of innate immune signaling pathways. Inclusion of exon
4 in the long isoform is mediated by mutant splicing factor (SF), U2AF1, which results in oncogenic
signaling and poor prognosis in MDS/AML (Smith et al., Nature Cell Biology, 2019). Importantly,
inhibition of IRAK4-L abrogates leukemic growth in vitro and in vivo. These findings established
that mutations in U2AF1 induce expression of therapeutically targetable "active" IRAK4 isoforms
and provide a genetic link to activation of chronic innate immune signaling in MDS. Our preliminary
RNA-sequencing studies in primary MDS samples reveal that (i) splicing factor SF3B1 mutations
also lead to the active IRAK4-L isoforms via retention of exon 6, and that (ii) a sizable proportion
of splicing factor (SF) wild-type MDS patients also exhibit expression of IRAK4-L. We hypothesize
that oncogenic IRAK4-L isoforms are critical for the function of SF-mutant (i.e. U2AF1 and SF3B1)
and a subset of SF-wildtype MDS disease propagating cells. As such, this proposal will
comprehensively evaluate the mechanistic basis of IRAK4-L regulation in SF3B1 and SF-wild
type MDS (Aim 1) by using isogenic cell lines expressing the SF3B1 K700E mutants and by
altering the expression of splicing modulator PRMT5. Aim 2 will determine downstream regulators
of oncogenic IRAK4 isoform activation in MDS. In addition to examination of NF-κB/MAPK
signaling, we will perform an unbiased phospho-proteomic screen to identify direct substrates of
IRAK4-L and examine their roles in hematopoietic dysfunction. Aim 3 will determine the efficacy
of IRAK4-L inhibition in MDS by a clinical-grade IRAK4 kinase inhibitor. In vitro sensitivity and
differentiation assays in U2AF1- and SF3B1-mutant, and SF wildtype MDS cells will be
conducted. Patient derived xenografts with U2AF1/SF3B1-mutant, and SF wildtype MDS will be
treated with the IRAK4 inhibitors to examine for suppression of the disease-propagating cells. We
will also determine whether overexpression of IRAK4-long isoforms is predictive of response in
an ongoing clinical trial of IRAK4 inhibitor. Taken together, these studies will determine the role
of splicing mutation induced IRAK4-L isoform in MDS pathobiology. Importantly, these studies will
lead to potential targeted clinical trials with clinically relevant inhibitors of IRAK4 in MDS.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) Myelodysplastic syndromes (MDS) are common blood cancers that are characterized by high rates of disease relapse. Our data show that the levels of active longer forms of IRAK4 are very high in MDS cells, are predictive of worse outcomes in patients, and can be used to target disease causing cells. In the proposed studies, we will determine the intracellular pathways activated by IRAK4 in MDS cells, and test the efficacy of novel IRAK4 inhibitors in MDS.